MULTIPLE DOSE SAFETY AND PHARMACOKINETICS OF BMS 180194 IN HIV SUBJECTS

Determine the safety, tolerance, and pharmacokinetics of BMS 180194 when given orally to HIV- and CMV-seropositive subjects twice daily for 28 days.